PRIDE Summer Institute in Cardiovascular Disease Comorbidities, Genetics and Epidemiology (CVD-CGE)

Project Summary/Abstract
This PRIDE renewal application from Washington University proposes to build upon our current SIPID/PRIDE
CVD-CGE program which has been successful with continuous funding for the past 16 years. The overarching
goal of our program is to enhance the diversity of the biomedical research workforce by providing creative and
highly-relevant training activities in focus areas related to cardiovascular disease (CVD). We will accomplish this
goal by providing mentoring and research training to junior faculty who come from backgrounds traditionally
underrepresented (URM) in the biomedical research workforce. Our program (13 cohorts, 76 mentees over
16 years) has been highly successful: at the 10-year follow-up, our mentees had: a) received 171 grants (2.3
grants/mentee); published 1,573 manuscripts (21 publications/mentee); and c) received academic promotions
with 48% having achieved rank of Associate Professor/Full Professor. Through the proposed activities listed
below, we plan to recruit 8 mentees each of the first 4 years, to be mentored and trained to develop independent
research careers in areas relevant to the mission of NHLBI with primary focus on CVD. We are adding two new
focus areas based on feedback from current and former trainees, faculty and mentors. Highlights of this renewal
application include: 1) Continue the two current cornerstone focus areas: “CVD epidemiology and
comorbidities”, adding “Global Health” under this focus area, and “Genetic Epidemiology”; 2) Add two new
focus areas: “Implementation Science” and “Data Science/Bioinformatics”, both of which are of strategic
importance to NHLBI and NIH; 3) Enhance our comprehensive mentoring and writing program, with a proven
track record for the past 16 years, to provide rigor and depth to scientific writing; 4) Form a new “External
Mentoring Pool & Recruiting Faculty Committee” composed entirely of our SIPID/PRIDE Alumni (former
mentees) that brings additional depth and mentoring capacity “by URMs for URMs”. For this renewal, we will
continue to focus on the development of competitive “Small Research Project (SRP)” grant applications during
SI-1, while SI-2 will focus on new NIH proposals. Based on mentee feedback, SI-1 and SI-2 has been revamped
into an 8-week program that includes “in person”, “hybrid” and “virtual” segments. This new format allows for
more time at home, yet maintains the academic rigor of previous SIs. A 3-day in-person overlap between new
and returning cohorts will facilitate networking and peer-mentoring. The year-long mentoring program includes
monthly mentoring meetings, a 3-day mid-year meeting, and a 4-day annual meeting in Washington, DC. Finally,
we will follow mentees for two years with bi-annual updates of their individual development plans, while also
focusing on grants and manuscripts writing and academic advancement, with follow up evaluations for up to 10
years. Primary program goals will continue to be focused on mentee success securing independent grant
support, scientific publications and academic promotions.

Public health relevance
Project Narrative Development of a diverse biomedical research workforce is critical to address health disparities among underrepresented minority racial and ethnic groups. This renewal of the Washington University PRIDE CVD- CGE program proposes state-of-the-art approaches to research training in cardiovascular disease epidemiology, comorbidities, genetic epidemiology, implementation science, and data science and bioinformatics. Mentored early stage investigators are more likely to succeed in their research efforts and be retained in academia.